Mouse Genetics

PROJECT SUMMARY/ABSTRACT
The Tisch Cancer Institute (TCI) Mouse Genetics Shared Resource Facility (MGSRF) provides TCI members
with access to state-of-the-art facilities for the production of transgenic and knockout cancer models in mice, as
well as related rodent embryology techniques. The MGSRF produces transgenic mice by injection of DNA
fragments into pronuclear stage single-cell mouse embryos, and assists laboratories with the production of
targeted mutant lines of mice through the use of mouse embryonic stem (ES) cells or CRISPR/Cas9 gene editing.
In addition to the creation of novel mouse lines, the MGSRF assists TCI laboratories with the maintenance of
existing lines through the cryopreservation of sperm, and with the import of novel lines from other institutions by
recovering mice from cryopreserved embryos or sperm, live embryos, or through the use of IVF rederivation of
individual males that are shipped to ISMMS. This Shared Resource Facility has a long-standing history of
creating mice for TCI laboratories, and the MGSRF’s role in the cancer programs will continue to strengthen and
enhance the ability of TCI members to conduct cutting-edge cancer research using novel mutant mouse models.